Enhancing Capability and Capacity of Marylandâs Laboratory to Conduct Surveillance of Antibiotic Resistance Pathogens in Selected Retail Foods

Abstract Food-borne bacterial infections contribute to morbidity and mortality world-wide. The National Antimicrobial Resistance Monitoring System (NARMS) was established to perform public health surveillance in the United States to track antimicrobial resistance in enteric bacteria isolated from retails food products. The MD Department of Health and Mental Hygiene has been participating in the NARMS program for numbers of years and successfully contributed to the development of the data used in the studies of bacterial illness to retail food contamination. The study has been performed in collaboration between the State of Maryland DHMH epidemiologists and laboratory scientists to assure the quality of the results. Retail foods including ground beef, pork chops, ground turkey and chicken breast with skin, are purchased by the MD DHMH staff from stores the Baltimore metropolitan areas every two weeks. The samples are processed according to the protocols for the presence of Salmonella, E. coli and Enterococci. The poultry samples are also tested for the presence of Campylobacter. Bacterial isolate’s identity are then confirmed with the appropriate methods. Additionally, we are capable of serotyping Salmonella isolates and speciating the other isolates using molecular methods. After all isolates are confirmed and frozen at -80°C, they are submitted to the FDA for antibiotic susceptibility testing and further characterization.

Public health relevance
PROJECT NARRATIVE Antibiotics have significantly contributed to the treatment of infectious diseases and inexorably changed the landscape of public health. Notably, antimicrobial resistance associated with food-borne pathogens has become a priority concern in public health. Food-borne pathogens can develop resistance to certain antibiotics via the exposure of antimicrobials primarily from excessive or incorrect use within agricultural practices leading to prorogation and circulation within our current food production system. These pathogens may also serve as reservoirs for antimicrobial genetic elements that may transfer to other pathogens. The growing trend of antibiotic resistance of food-borne pathogens continues to elevated concerns of food safety within the U.S. food system. The main goal of this project will be the isolation and characterization of four different microorganisms for Salmonella, Campylobacter sp., E.coli and Enterococcus sp. from different retail meats. These isolates are subjected to downstream phenotypic and genotypic characterizations. The identity of these isolates will be confirmed before submission to the FDA for further characterization. In addition to pathogen isolation, the Laboratories Administration has the capability and capacity to use advanced technologies to further characterize these isolates including speciation, serotyping, and whole genome sequencing.